Capillaric microfluidics for integrated, self-powered, and self-regulated sample preparation in miniaturized mass spectrometry systems

PROJECT SUMMARY/ABSTRACT
Mass spectrometry (MS) stands as a cornerstone of analytical techniques used across various fields of biological
and chemical sciences. Its ability to provide detailed molecular information makes it indispensable for both basic
and applied research. Miniaturized mass spectrometers offer significant benefits in areas relevant to NIGMS
priorities by enabling rapid, on-site biochemical analysis and diagnostics in resource-limited or decentralized
environments, which can advance precision medicine, public health, and fundamental biomedical research. Their
portability allows for real-time monitoring of disease biomarkers, therapeutic drug levels, and metabolic states
directly at the point of care, facilitating timely interventions. While miniaturized MS systems excel in portability
and real-time analysis, they typically lack the versatility and thorough sample separation of conventional systems,
limiting their applicability to a narrower range of sample types. Integrated sample preparation strategies that
improve the matrix tolerance, accuracy, precision, and versatility of miniaturized MS instruments are crucial to
address the growing need for decentralized diagnostic tools in both clinical and field environments. Microfluidics
offer precise control, reduced sample volumes, and improved reproducibility, and are a promising platform for
automated sample preparation. However, current microfluidic approaches have complexity and cost issues. 3D-
printed capillaric microfluidics present a promising solution. They allow rapid prototyping and eliminate the need
for complex instrumentation, making them accessible to non-experts and diverse scientific fields. The
overarching goal of this ESI MIRA grant is to develop capillaric microfluidics for integrated sample preparation
in mini-MS systems. The research will focus on three broad research areas that align with NIGMS's mission of
advancing basic biological processes and translational applications, namely: (1) integrating capillaric
microfluidics with mini-MS cartridges and ionization systems, (2) automating dried reagent rehydration and
addition of internal standards and derivatization agents, and (3) implementing solid phase extraction and assay
validation with clinical samples. The detection of antiretroviral drugs and a comparison with traditional MS will
be used as a proof-of-concept to demonstrate accuracy and precision of the developed technologies. This project
aims to revolutionize sample preparation in mini-MS, making it more accurate, precise, and versatile, and
ultimately benefiting scientific research and diagnostics. The PI has a strong background in bioengineering and
has made key contributions to the design, 3D-printing, and applications of capillaric microfluidics. This project
has the potential to uncover new long-term directions and innovations both in the development of microfluidic
technologies and their application to a wide a variety of fields.

Public health relevance
PROJECT NARRATIVE Mass spectrometry (MS) is a vital analytical tool in biological and chemical sciences, and miniaturized MS systems offer rapid, on-site biochemical analysis in decentralized environments. This project aims to develop capillaric microfluidics for improved sample preparation in mini-MS systems, enhancing their accuracy, precision, and versatility. By integrating capillaric microfluidics with MS cartridges, automating reagent handling, and validating assays with clinical samples, the research will advance decentralized diagnostics and precision medicine.